Towards intra-operative guidance in brain tumor surgery using real-time resting-state functional MRI

Executive Summary
The long-term goal of this technology development is to improve the clinical utility of resting state fMRI (rsfMRI)
for presurgical and intra-operative mapping of resting state networks (RSNs) by developing an analysis tool
that can be seamlessly integrated into the presurgical and intra-operative workflow. RsfMRI is a rapidly
advancing task-free approach for pre-surgical and intra-operative mapping of RSNs in patients with brain
tumors who have difficulties performing tasks. The technology builds on TurboFIRE, a powerful real-time tfMRI
and rsfMRI analysis software tool for high-speed fMRI, the success of a prior Phase I STTR study in 12 brain
tumor patients that showed clinically acceptable concordance of real-time high-speed multi-echo rsfMRI with
tfMRI, and intra-operative electrocortical stimulation (ECS); and our experience with intra-operative rsfMRI in
anesthetized brain tumor patients. This technology provides online rsfMRI mapping, eliminating time-
consuming postprocessing, and seamless integration into presurgical planning and intra-operative MRI.
The objectives of this phase I STTR effort are (a) to develop a fully automated real-time resting state fMRI
analysis tool that enables online monitoring of data quality and computation of patient specific maps of resting
state connectivity, and (b) assess the performance of this tool for robust presurgical mapping in patients with
brain tumors. The goal is to develop real-time functional brain imaging technology with high sensitivity and
specificity that is competitive with four state-of-the-art offline toolboxes.
The specific aims for Phase II are to (1) develop a real-time rsfMRI analysis tool with online quality control for
intraoperative guidance, (2) Validate the technology for presurgical and intra-operative rsfMRI in patients with
brain tumors (3) Prepare the documents required by CFR 820.30c for FDA 510(k) clearance.
This technology will have significant clinical and commercial potential for a wide range of neurological
and psychiatric applications beyond pre-surgical mapping in patients with brain tumors. It opens up
functional brain mapping to patient populations that have been difficult to study in the past.
Since we submitted the grant application, the FDA-approved offline resting state fMRI analysis tool Quicktome
from Omniscent has become available, which, however, does not offer real-time analysis and thus is not
suitable for intraoperative mapping. This along with the efforts of several companies, including major MRI
manufacturers, who are working on prototypes documents the increasing market needs for resting state fMRI.
We have an operational TurboFIRE prototype that was used in two recent feasibility studies in patients with
brain tumors. (A) We carried out a feasibility study on non-stationarity of resting-state connectivity in patients
with brain tumors in the awake and anesthetized state in preparation for Specific Aim 1b of Phase I and
Specific Aim 1a of Phase II, which was submitted to the 2024 ISMRM Annual Meeting (Fig. 1). (B) We carried
out a
feasibility
study on
artificial
intelligence
(AI)-based Figure 2. Peritumoral connectivity using deep
learning-based tissue prediction in patient with
Figure 1. Group- and scan-averaged test-retest reliability (ICC tumor tissue glioblastoma. (a) Intraoperative view (b) Electro-
values) during (a) awake state and (b) anesthesia and (c) difference segmentation cortical stimulation localization (crosshair) during
showing increased inter-cortical ICC values during anesthesia. language task inhibition overlaid on T2 MRI (c) Peri-
for seed- tumoral connectivity using AI-based seed selection
based mapping of peritumoral resting-state connectivity in patients in peri-tumoral edema medial and in proximity to (d)
with glioblastomas in preparation for Specific Aim 1a of Phase II, Exner’s language area in tfMRI (verb generation).
which was presented at this year’s ISMRM Annual Meeting (Fig. 2). We also started comparing rsfMRI
connectivity mapped with two state-of-the-art offline toolboxes in a Human Connectome Project data set.
The I-Corps team consists of:
Dr. Stefan Posse is a Co-PI of the STTR grant and internationally recognized for the development of real-time
fMRI since the late 90s and has over 30 years of experience in biomedical MR research with several patents
advancing the field of real-time functional MRI with the TurboFIRE technology. As the Technical Lead/Expert
he will be responsible for guiding the technology and patent research of the market discovery strategy.
Ms. Jacintha, FACHE is a C-level Corporate Officer (COO/CFO) of Neurinsight LLC who has more than 16
years of experience managing national and international health care organizations, including Sandia National
Labs, and 6 years of neuroimaging research experience with PET and fMRI. She will carry out customer
discovery and market profitability research and market growth analysis.
John Chavez, MBA is a serial entrepreneur and involved in 12 enterprises and startups. He served as President
of New Mexico Angels and currently heads the New Mexico Start UP Factory. He will provide guidance with
developing the market research strategy and monitor the progress of the market discovery objectives.
All three members are committed to the time requirements of the program.

Public health relevance
Narrative Surgical removal of brain tumors requires a delicate balance between maximum resection of the tumor and maximum preservation of neurological function, also known as maximum safe resection. Resting-state functional Magnetic Resonance Imaging (MRI) is a rapidly developing approach for presurgical mapping of cortical brain function that does not require patient participation. It can complement task-based functional MRI in patients who have difficulties performing tasks and can efficiently map a large number of functional brain systems to guide surgery. It replaces traditional approaches of functional MRI that require patient participation in patients with functional impairment and holds considerable promise for intra-operative guidance of minimally invasive surgery. Here, we propose a fully automated, highly sensitive and cost-effective real-time resting-state functional Magnetic Resonance Imaging analysis software tool on a custom high-performance computer workstation for presurgical and intraoperative mapping of cortical brain function, building on TurboFIRE, a powerful real-time rtfMRI and sfMRI analysis software tool and the success of a prior Phase I STTR program. This approach meets urgent clinical needs and has high commercial potential for seamlessly integrating resting-state functional Magnetic Resonance Imaging into the clinical workflow of presurgical planning and intra-operative MRI. This technology will have significant clinical and commercial potential for a wide range of neurological and psychiatric applications beyond pre-surgical mapping in patients with brain tumors. It opens up functional brain mapping to patient populations that have been difficult to study in the past.